KY DPH-DLS Environmental & Food Surveillance Testing

Overall Project Summary: RFA-FD-25-007 3/06/25
KY DPH-DLS Environmental & Food Surveillance Testing
In order to properly and effectively conduct food surveillance and provide consumer protection in our
state, regulating entities and laboratories need not just, the capability, but an enhanced ability to
ensure that the manufacturing and production standards are being instituted and maintained to the
highest degree of safety and quality. ISO/IEC 17025 standards have become vital to many regulating
bodies when it comes to assessing the reliability and level of food safety practices. Kentucky Division
of Lab Services (DLS) is fully accredited, in both Environmental Microbiology and Environmental
Chemistry food testing, with ISO17025:2017 and maintain a quality management system compliant
with the standard. Our KY SRPs have an agreement with the FDA and maintain the MFRPS standard
10 with our support and SRP, maintains a Sampling Agreement mirroring the prescribed LFFM
Sampling Guide. Our current scopes include chemical testing for mercury in fish using the Milestone
DMA-80 and EPA method 7473, also pesticide residue detection and quantification in produce
utilizing both AOAC and FERN methods. The scope of microbiological testing for pathogens is
carried out primarily using the FDA BAM but also FERN and AOAC methods. BAX Q7 and ABI 7500
PCR analysis includes Salmonella, Listeria, E. coli O157:H7 and other STECs but also organisms
associated with food quality such as quantification of aerobic, coliform and E. coli bacteria. We are
also capable of determining additional information concerning food quality by testing for food
pathogens such as, Campylobacter, Shigella, C. perfringens, S. aureus and SE Toxin, B. cereus, as
well as C. sakazakii. We use the Illumina MiSeq sequencing platform and have established a
collaborative agreement with the University of Kentucky College of Agriculture to support the WGS
throughput track by sequencing agricultural isolates for enteric pathogens. We also have an MOU in
place to provide testing of agricultural waters and farm samples when “for cause” samples are
collected. We perform testing on behalf of the KY State manufactured food regulatory program
(MFRPS) in the Department for Public Health / Food Safety Branch, which has a current food-safety
inspection contract with the FDA and is enrolled in the MFRPS. As a member of FERN, we have the
ability and facility to support testing for select agents using FERN methods. Both, the microbiology
and chemical analysts are in the federal select agent program (SAP) and have access to BSL2 and
BSL3 facilities onsite. The KY DLS is active in the Genome Trakr network meetings, calls, and
trainings. We currently have 2 analysts that have gone through the Galaxy Trakr training and have
been able to use it to its capacity. We are now fully capable of submitting metadata and sequences to
NCBI directly, using the NCBI submission portal using this format, Bio-sample and SRR. DLS has the
capability to assess sequence quality using the MicroRunQC tool in the GalaxyTrakr portal prior to
submission. In summary, none of this is sustainable without funding and we are more than
ready to assist other states and the FDA if the need arises.
1

Public health relevance
Overall Project Narrative: RFA-FD-25-007 3/11/25 KY DPH-DLS Environmental & Food Surveillance Testing KY DPH-DLS is accredited to the AIHA/ISO17025:2017 standard for food chemistry and microbiology. We have access to multiple molecular identification platforms and Mass spec for chemistry. We are supported by the KY SRPs/MFRPS and can submit sequencing data using Genome Trakr and NCBI. We are capable of direct reporting to the FDA via FSDX portal. We can and will share resources when requested.